Mitochondrial Transplantation Conference

Project Summary: Mitochondrial transplantation (MT) is a new potential therapeutic with
implications for the treatment of a wide variety of bioenergetic conditions, from cardiac arrest,
to aging, cancer, obesity, and stroke. Despite rising interest in MT over the past five years, MT
researchers have never had a conference focused on their work. Mitochondrial medicine is at a
critical juncture in its development as a field: while researchers have published many promising
results in animal models and even begun a human trial based on those results, it is not yet a
large, stable, well-funded field. An NIH-funded, national conference will connect a network of
academic and industry scientists still largely working in isolation from one another. Without a
conference dedicated to MT, these researchers will remain siloed in their own labs and
institutions, hampering the progress of this potentially paradigm-changing therapeutic. To that
end, we are requesting funds to support the first-ever conference focusing on MT.
Our speakers include the founder of mitochondrial medicine, Dr. Doug Wallace, and the first
person to undertake a Phase 1 human trial of MT in the brain, Dr. Melanie Walker. We are also
soliciting oral abstracts and posters from young investigators. The conference will focus on
current MT research, such as transplantation modalities, mechanistic hypotheses, and the
therapeutic value of mitochondrial transplantation. Patient advocates will also speak about the
impact of mitochondrial disease on themselves and their families. We aim to use this initial
conference to lay the groundwork for an annual, flagship international conference for MT.
Collaborations stemming from the conference may accelerate the development of clinically
relevant therapeutics for mitochondrial dysfunction.

Public health relevance
Project Narrative: When scientists discover a new potential treatment for serious health conditions, they must meet routinely in person at scientific conferences to share their ideas, so they can bring that treatment from theory to reality. Mitochondrial transplantation is just such a new treatment: it takes healthy mitochondria—the parts of your cells that make energy—and transplants them into a person that is dying from a heart attack or stroke to help them recover. While scientists are excited about mitochondrial transplantation, they have never had a conference dedicated to it: we propose to hold such a conference in Manhasset, NY in April, 2025.